Biocatalytic Synthesis of N-N and C-N Heterobiaryl Atropisomers

PROPOSAL SUMMARY
Atropisomerism is a type of chirality that arises from restricted rotation about a bond. Introduction of
atropisomerism to small-molecule drug candidates can improve potency, selectivity, and ADME (absorption,
distribution, metabolism, and excretion) properties. An underexplored class of atropisomers are heterobiaryl
atropisomers featuring an N–N or C–N atropisomeric axis. These classes of atropisomers have demonstrated
potent pharmaceutical properties. However, as compared to C–C atropisomers, there are relatively few
enantioselective methodologies for their synthesis. Most strategies rely on the derivatization of substrates
already containing the N–X bond (where X = N or C). An underexplored approach is the direct coupling of two
heteroarene fragments that form the N–X bond atroposelectively. However, known methods require the pre-
functionalization of starting materials, thereby limiting the generality of these strategies.
Nature, on the other hand, synthesizes heterobiaryl atropisomers by a direct oxidative coupling, wherein an
N–H and X–H bond undergo direct conversion into an N–X bond under mild reaction conditions. Flavin-
dependent aromatic hydroxylases (FDAH) are an enzyme class with demonstrated N–N and C–N coupling
reactivity. The research outlined in this proposal will draw upon this known reactivity to develop general strategies
for the synthesis of N–N and C–N heterobiaryl atropisomers. Towards this goal, I will employ bioinformatic
techniques to develop a library of FDAH enzymes to explore this unique coupling reactivity. From the reactivity
profile of this FDAH enzyme library, I will identify features of these enzymes that contribute to the site-selectivity
of this oxidative coupling approach. Employing both enzyme library reactivity profiling and protein engineering, I
will develop atroposelective N–N and C–N biocatalytic coupling strategies. The methods developed herein will
provide access to a class of medicinally relevant atropisomers that are difficult to obtain by other approaches.

Public health relevance
PROJECT NARRATIVE Atropisomerism, or chirality that arises from restricted rotation about a bond, is an important design principle in drug discovery due to its ability to increase the potency and binding selectivity of small-molecule drugs. N–N and C–N heterobiaryl atropisomers demonstrate potent pharmaceutical properties, yet few methods exist for their atroposelective synthesis. This proposal seeks to develop a biocatalytic strategy for the atroposelective synthesis of these medicinally relevant classes of atropisomers.